RESPONSE OF HDM ALLERGEN BRONCHOPROVOCATION OF ASTHMATICS

The purpose of the study is to examine whether exposure of mild atopic asthmatics to 0.16 ppm ozone causes an increase in their bronchial allergic response to inhaled house dust mite allergen. Ozone is the major component of photochemical smog and over one third of the U.S. population lives in areas that are not compliant with the current ambient national standard.